Administrative Core

The Administrative Core has three major responsibilities. The first is to facilitate the various administrafive aspects associated with the business of running the program including record keeping, scheduling, financial bookkeeping, progress reports, manuscripts, etc. The second is to foster scientific progress and coordination, both between projects and program investigators, but also with scientists outside of the participafing universities. This includes coordinafing communicafions and travel between the locafions of the Project Leaders, the Medical College of Georgia and the University of Utah as well as the Co-Investigator at the University of Texas at San Antonio. Finally, the Administrative Core will provide biostatistical, database management, and computing resources for each of the projects in the program.

Public health relevance
The Program Project focuses on elucidating mechanisms by which the kidney controls sodium excretion, and therefore, has direct relevance to the serious health problem of salt-dependent hypertension and kidney disease. The Administrafive Core plays an important role in coordinating these activities, which is particulariy important in the current program due to the integration of diverse range of scientific expertise.